2022 Nasopharyngeal Carcinoma Gordon Research Conference

Abstract
Nasopharyngeal carcinoma (NPC) and oropharyngeal carcinoma (OPC) are 2 common head and neck epithelial
cancers that are associated with viral infection. Although both cancers arise from the pharynx, their anatomic
and geographic distribution as well as viral linkage are distinct. NPC, which is linked to the Epstein-Barr Virus
(EBV), is localized to the nasopharynx and has the highest incidence in Southeast Asia, North Africa, Greenland,
and Alaska. In the United States (US), it is rare among Caucasians but is common among ethnic Asians,
Hispanics and African Americans. In contrast OPC, which is commonly linked to the Human Papillomavirus
(HPV), is localized to the oropharynx and has the highest incidence in white males in the Western hemisphere.
The etiologies of these two unique cancers include three significant co-factors: host genetics, viral infection and
environmental influences. How these factors contribute to the development of these cancers is the research
focus of numerous laboratories worldwide. Because of their locations and proclivity for early lymphatic spread,
both NPC and OPC are diagnosed at advanced stage, requiring aggressive therapy. Understanding how viral
infection drives normal cells to become cancerous, how these cells escape from immune surveillance, and the
critical pathways mediating tumor progression and treatment resistance are expected to lead to better tools for
early diagnosis and effective therapies that would ultimately improve outcome of these cancers.
The convergence of a virus infection, host genetics, host immune function, and epidemiological factors, makes
these two cancers powerful models to delineate the host-virus-environment interactions, thereby yielding new
insights into tumor pathogenesis. Importantly, the inclusion of two different virally driven cancers at the same
small, intimate meeting will catalyze collaborations and advance the pace of research in both cancers. We
hypothesize that the 2022 meeting, which features cutting edge basic, translational, and clinical research in NPC
and OPC and provides a unique forum for idea exchange among basic scientists, clinicians, and industry, will
help to expand the translation of new knowledge to patient care. We will address this hypothesis via three specific
aims: (1) To advance the overall knowledge in research and clinical care of NPC and OPC through the
development of an exciting scientific program and provision of a stimulating forum for critical interactions between
the basic and clinical scientists; (2) To foster the career development and enhance the visibility of new
investigators and trainees through the mini talks and highly engaged poster sessions and provision of partial
meeting support; and (3) To enhance the diversity of NPC GRC participants with a focus on woman and URM
attendees and those from developing countries (where NPC is endemic) through our effort to provide partial
meeting support and promote oral presentations from these groups. We believe that the scientific environment
created at the 2022 NPC/OPC GRC meeting will help to advance the field of research in virally-driven head and
neck cancers in order to improve the overall care and cure of these patients.

Public health relevance
Narrative Viral infections are associated with several human cancers, including the Epstein-Barr virus (EBV) in nasopharyngeal carcinoma (NPC) and the human papillomavirus in oropharyngeal carcinoma OPC). By studying these two neighboring head and neck cancers as models of virus-induced cancers, it will help to unravel the relationship of virus infection, host immune response, host genetics, and epidemiological factors that contribute to development and progression of these devastating cancers. The 2022 NPC Gordon Research Conference will bring together the needed basic scientists and clinical experts in all these areas to brainstorm new ideas which will expedite advances in the field and translate new findings into the clinic.